The Center for Accelerating Practices to End Suicide through Technology Translation (CAPES)

CAPES OVERALL: PROJECT SUMMARY/ABSTRACT
Significance: Recently, we have seen massive growth in availability of empirically supported technologies
enabling suicide risk identification, monitoring, and prevention in healthcare settings. However, our knowledge
of effective, efficient strategies to translate these technologies into clinical practice is weak. As a result, these
technologies are not being optimally deployed to prevent suicides. The Center for Accelerating Practices
to End Suicide through Technology Translation (
CAPES
) will bridge this research-to-practice gap.
Investigators: CAPES transdisciplinary Faculty, Advisors, and Consultants have extensive expertise in the
disciplines required to successfully support the CAPES mission and its individual projects, producing synergistic
insights and discovery. Combined, the team has over 1,000 high-impact publications in fields relevant to or
directly studying the intersection of suicide prevention, implementation science, digital health technology
development and translation to practice, health disparities, study design and analysis, and healthcare systems-
based change. This scientific depth will be accompanied by longitudinal engagement of diverse stakeholders.
Innovation: CAPES will be the first NIMH center focused on accelerating evidence-based suicide care by
leveraging technology solutions across multiple healthcare settings. Further, it will leverage innovations in
implementation science, person-centered design, hybrid clinical trial design, technology-related economics
evaluations, business development, and ethics to maximize scientific and public health impact.
Approach: The CAPES Administrative Core will collaborate with the Methods Core to maximize the Center’s
impact by creating synergy; prioritizing evidence-based, scalable technologies for study; creating relevance
across multiple settings and diverse patient populations; leveraging the Zero Suicide framework to align with
priorities of the National Action Alliance for Suicide Prevention and NIMH; and fostering business development
and technology transfer to help ensure successful public dissemination, adoption, and sustainability.
Environment: UMass and Worcester Polytechnic Institute have an established history of successfully
carrying out collaborative studies and are perfectly situated to support this Center. Their networked capabilities,
combined with other academic, health system, business, and community partners, provide layered,
complementary resource access for clinical care improvement, technology development, technology transfer
from research settings to clinical use, and widespread dissemination of CAPES resources.
Impact: Led by accomplished investigators with access to powerful resources, CAPES will be ideally situated
to answer the critical research questions posed in this proposal and reach many diverse settings and patient
populations. CAPES innovative embrace of evidence-based suicide care technologies, combined with a strong
focus on Zero Suicide alignment, implementation science advances, technology transfer, and multi-channel
dissemination, position it for transformational impact on suicide prevention in healthcare settings.

Public health relevance
CAPES OVERALL: PROJECT NARRATIVE The potential public health impact of The Center for Accelerating Practices to End Suicide through Technology Translation ( is profound, because the knowledge generated will be relevant to many diverse settings and populations at risk for suicide. CAPES will identify the best evidence-based suicide care technologies and study them systematically to identify key strategies for maximizing their translation to clinical care so they can be put in the hands of clinicians, patients, and families instead of sitting on the “virtual shelf.” This improved ability to identify and monitor suicide risk and provide high-quality care for individuals identified as at-risk will reduce suicide attempts and suicide, which also prevents the suffering experienced by families, friends, and communities that results from losing someone to suicide. CAPES )